UW Radiological Sciences Training Program

ABSTRACT
This training program prepares pre-doctoral & post-doctoral trainees for careers where they will invent the
physics and engineering of new tools and techniques that will lead to discoveries in cancer research and in the
management of cancer patients. The research specializations cover a broad range of technologies in disease
diagnosis, personalized treatment and delivery assessment, with the core focus being applied medical physics
research in cancer. The 34 faculty mentors with another 22 participating faculty in the core departments include
Medical Physics, Radiology, Human Oncology (Radiation Oncology), Physics and Electrical Engineering faculty,
who have a broad spectrum of collaborations with other clinical and basic science researchers. Translational,
team-driven research includes traditional x-ray, CT, MRI, ultrasound, optical and PET/SPECT imaging with the
Department of Radiology, and radiation physics, radiation biology, and radiation therapy with the Department of
Human Oncology. Trainees are intimate participants in these research programs as collaborators, publishing
joint research articles, and learning the skill to apply for extramurally funded grants and contracts. Extensive
faculty contact provides leadership and supervision, including weekly lunch visits with visiting colloquia faculty.
Pre-doctoral trainees in Medical Physics take two years of didactic medical physics training progressively
oriented towards their research specialization, and are typically voted into this training program after passing
their oral qualifier, with a preliminary research plan related to cancer. This design has significantly increased the
likelihood of their remaining in cancer-related research and shortens their typical time in the NRSA position to 2
years, funded both before and after by their primary advisor. Post-doctoral trainees are encouraged to broaden
and deepen their academic training by auditing appropriate courses, and their appointments are typically 2 years.
Both predoctoral and postdoctoral trainees must take or audit additional research ethics courses, take cancer-
specific courses, attend relevant cancer grand rounds presentations, and must participate in a newly created
course on the PhD Scientist Profession, including instruction on patenting, business startups, grant writing,
career guidance and one-on-one mentoring. Trainees give seminars, attend colloquia, present research results
at local, national, and international meetings, and co-author articles and reports. An annual Training Grant
Symposium provides additional opportunity for trainees to present research results to the Medical Physics and
collaborating faculty. Additionally, a newly created biennial Symposium/Workshop on Emerging Leaders of
Academic Medical Physics includes their participation with networking, diversity building and ideation of research
vision. The program benefits from an external advisory board of T32 directors in medical imaging and cancer,
as well as active participation by 16 physician-scientists. Trainees in the program are exceptionally well prepared
to assume leadership positions as visionary researchers and academics in the application of physics to cancer
prevention, diagnosis, and treatment.

Public health relevance
Project Narrative: This training program prepares advanced predoctoral students and postdoctoral trainees in the radiological sciences of cancer research and treatment with the skills needed to advance their careers and their science. Researchers in this field continue to have a high impact on the diagnosis and treatment of cancer, leading to major advances particularly in the areas of medical imaging, image guided intervention and radiation therapy.